Core 1: Sample Procurement and Clinical Core

Abstract:
The proposed Sample Procurement and Clinical Core (SPCC; Core 1) has been designed to provide a unified,
comprehensive, and centralized service for collecting patient samples (both retained clinical specimens and
prospectively collected blood samples) to support the studies of Projects 1-3 and Core 2. The SPCC is an
outgrowth of similar (unfunded) activities initiated, optimized, and expanded beginning in February 2020, at
beginning of the COVID-19 pandemic. The SPCC will coordinate IRB applications, study participant recruitment,
sample procurement (including operationalizing blood collections by hospital phlebotomists to reduce
venipunctures per patient and PPE use), sample processing, and sample distribution to Projects 1-3 and Core
2. SPCC activities will be performed by regulatory specialists, clinical investigators (from rheumatology,
oncology, hematology, and infectious diseases), clinical pathologists, nurse-coordinators, and trained
technicians. This group’s efforts will be coordinated through regular meetings between leadership of the 3
Projects, Core 2, and the Administrative Core. The SPCC activities will achieve the following Specific Aims:
Aim 1: To extend our existing retained clinical sample repository to support prospective serosurveillance for the
target populations of this Program. The SPCC will expand our existing retained sample repository by
specifically targeting samples from patients of interest to this Program (eg, systemic lupus erythematosus
[SLE]). The resulting longitudinal biorepository will support detailed serial serosurveillance studies by Core 2.
Aim 2: To coordinate all regulatory, recruitment, sample procurement, processing, distribution, and storage
activities for prospective blood collections required for Projects 1-3. SPCC investigators will maintain
comprehensive IRB approval(s) for prospective collection of clinical samples. They will closely collaborate
with investigators from all Projects to consolidate sample needs, and develop a schedule for efficient sample
collections to meet the needs of Projects 1-3. Staff will coordinate collections, assign sample study numbers,
aliquot and label samples, and then either distribute to investigators from individual Projects or store frozen
until needed. Samples and patient metadata will be entered into a secure RedCap database.
This Core allows U54 investigators to take optimal advantage of unique strengths at Emory including large
populations of rheumatology, multiple myeloma, and lung cancer patients, as well as large percentages of
African-Americans in these groups. Additionally, this Core facilitates patient enrollment at all 6 distinct hospital
sites and affiliated institutions (eg, Grady Memorial Hospital). Core staff will maintain a comprehensive RedCap
database on each patient, including metadata and test results, which will be invaluable for later data mining.

Public health relevance
Narrative: All of the studies proposed in this U54 Program require blood samples from COVID-19 patient with particular underlying diseases, including systemic lupus erythematosus, rheumatoid arthritis, and multiple myeloma. This Core is in charge of collecting those samples and distributing them to each Project in the most efficient and effective manner possible.